NEUROPROTECTIN D1 IN TRANSGENIC RATS EXPRESSING RHODOPSIN MUTATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Specific Aim 1. To test the hypothesis that Neuroprotectin D1 (NPD1) will protect retinal pigment epithelial (RPE) cells and photoreceptors in the Ccl2/Cx3cr1-deficient (double knockout, DKO) mouse model for age-related macular degeneration (AMD). Specific Aim 2. To test the hypothesis that RPE cells over-expressing pigment epithelium-derived factor (PEDF) and enriched with Docosahexaenoic acid (DHA) will slow down photoreceptor loss in DKO mice. Specific Aim 3. To test the hypothesis that NPD1 will inhibit choroidal neovascularization (CNV) in DKO mice.